Increased Adiposity Risk after Prenatal Alcohol Exposure

? DESCRIPTION (provided by applicant): Fetal Alcohol Spectrum Disorder (FASD) is no longer just the largest preventable cause of neurodevelopmental disability. Children with FASD have inappropriate feeding behaviors and overconsume calories and sugar. They also appear to have an increased obesity risk at adolescence. The long term metabolic consequences and underlying mechanisms of this obesity risk are understudied and unknown. Previous animal models of PAE also identify increased adiposity and focus on dysregulation of glucose metabolism, but alcohol affects many pathways and organ systems and there are likely multiple mechanisms by which PAE increases obesity risk. This application tests the hypothesis that dysregulation of lipid metabolism contributes to the increased adiposity of PAE. I will investigate this hypothesis using a mouse model of gestational binge alcohol exposure and study the mechanism underlying this increased adiposity risk after PAE. Aim 1a uses indirect calorimetry to quantify how PAE affects systemic energy balance, as well as the animal's ability to adapt its lipid and glucose metabolism in response to high dietary lipid and carbohydrate challenge. Aim 1b investigates how PAE alters the action of key proteins and signals that regulate lipid metabolism and fate. Taken together, these findings form the foundation for a future K-award application that will detail these mechanisms at the cellular and molecular level. This work will substantially expand our understanding of how PAE increases risk for obesity and later life metabolic disease, and will generate future hypotheses regarding its mechanism and treatment. Because elevated adiposity increases chronic disease risk and reduces quality of life, it is important to understand and address issues that preclude individuals with PAE from living a healthy lifestyle.

Public health relevance
PUBLIC HEALTH RELEVANCE: As obesity reaches pandemic levels, it is important to identify risk factors for this and other metabolic diseases that originate in utero or childhood. Fetal alcohol spectrum disorder (FASD), the result of alcohol exposure during pregnancy, affects up to 4 children in a 100. Children with FASD are at risk for increased obesity at adolescence, and obesity risk is well-known to increase later risk for chronic metabolic disease. Many of these children exhibit disordered feeding and a lack of satiety. It is important to investigate the mechanisms behind these issues, in order to differentiate between inherent physiology and environmentally derived issues and work to solve them individually or together.